BET Bromodomain Epigenetic Control of Macrophage Inflammatory Activation

PROJECT SUMMARY
Sixty percent of people worldwide die due to inflammatory diseases like cardiovascular disease, chronic
obstructive pulmonary disease (COPD), and stroke. This highlights the need for an improved mechanistic
understanding of the initiation and progression of inflammation. Macrophages are ubiquitous in all major
tissues and play an essential role in inflammation, driving the development and progression of inflammatory
disorders by secreting cytokines and other inflammatory mediators. Proinflammatory macrophage activation is
initiated via NF-κB signaling, a master transcriptional regulator of inflammation. However, broad inhibition of
the NF-κB pathway results in many unacceptable patient toxicities, including impaired tissue repair. Recent
studies have shown that the bromodomain and extraterminal domain (BET) family of epigenetic reader proteins
promote transcription of a subset of NF-κB-regulated inflammatory target genes in a cell- and context-specific
manner. Small molecule inhibitors of the BET family (BETi) provide broad anti-inflammatory effects,
significantly decrease macrophage-mediated inflammation, and exhibit beneficial anti-inflammatory effects in
several inflammatory disease models by attenuating a subset of NF-κB target genes. However, the
transcriptional mechanisms by which BETi modulate inflammatory gene transcription remain largely unknown.
The BET family consists of four members (BRD2/3/4/T), each with two independent acetyl-lysine binding
bromodomains (BD1 and BD2). Most studies of BET transcriptional regulation use non-selective BETi that
block both BD1 and BD2 across the entire protein family (pan-BETi). In clinical trials, pan-BETi are associated
with significant adverse effects and dose-limiting toxicities. Thus, BETi with improved selectivity for a subset of
BET bromodomains are urgently required to improve inflammatory disease treatment options. We are
determining the specific role of BET proteins and their individual bromodomains in macrophage activation and
contrasting that activity to BET protein functions in non-immune cells. While our prior work has suggested that
BRD4-BD1 is required for non-immune cell inflammatory transcription, our preliminary studies in macrophages
suggest that both bromodomains of BRD2 promote inflammatory transcription. Here, we will elucidate the
precise biochemical mechanisms and individual BET bromodomains regulating macrophage inflammatory
activation and identify the exact protein interactions underlying that regulation. Aim 1 will identify the precise
transcriptional role of each BET bromodomain in macrophage inflammatory activation with a focus on BRD2.
Aim 2 will examine the BET bromodomain-based protein interactions that drive BET protein nuclear localization
and activity. This fellowship addresses knowledge gaps in the biochemical mechanisms underlying BET
bromodomain control of macrophage inflammation. Completing this fellowship will further develop precision
medicine approaches for inflammatory disorders by identifying which BET bromodomains are the most
attractive therapeutic targets to modulate inflammation with fewer off-target toxicities.

Public health relevance
PROJECT NARRATIVE Sixty percent of people worldwide die from diseases linked to inflammation, like chronic obstructive pulmonary disease and cardiovascular disease, which are driven by immune cells called macrophages and the signals they produce. We have found that BET proteins, which help control inflammation, act differently in macrophages compared to other cell types. This project aims to find out how BET proteins control macrophage activity during inflammation, paving the way for new treatments that reduce inflammation in diseases like chronic obstructive pulmonary disease and cardiovascular disease with fewer side effects.